Toxoplasma Surface Antigens and Immunity

The protozoan parasite Toxoplasma gondii infects all nucleated cells and establishes life-long chronic infections in virtually any warm-blooded vertebrate. Eliminating the ability of this parasite to establish chronic infections in humans and animals is central to controlling its pathogenesis, however, there is currently no human vaccine or drug capable of doing this. Our lab has identified a large superfamily of >180 SRS protein adhesins that are essential for 1) entry into host cells and 2) regulating host immunity in order to establish chronic infections. The SRS proteins are regulated in a development-specific manner, and we showed by gene-knockout studies that four of these antigens expressed by the tachyzoite stage are critical virulence factors: SAG1, SAG2, SRS2 and SAG3. SAG3 is a pivotal adhesin required for establishing infection, whereas SAG1, SAG2 and SRS2 are primarily immunomodulating factors that elicit strong immunity in all infected hosts. Our work with SRS2 identified that the majority of mouse virulent Toxoplasma strains poorly express SRS2, whereas all avirulent strains highly express SRS2. We tested whether the expression level of SRS2 was sufficient to alter the mouse virulence phenotype. When SRS2 was expressed transgenically in a virulent strain at levels equivalent to those found in avirulent strains, the transgenic strains were no longer virulent. These data suggest that SRS2 is a pivotal virulence factor and that expression level is a critical determinant governing the outcome of infection. Understanding the structural basis and cellular receptor for host cell entry within this superfamily of SRS antigens, and the type of immunity induced during natural infections should lay the foundation for therapeutic interventions, either prophylactic or vaccine-based, to limit infectivity and induce sterilizing immunity against this widespread zoonotic pathogen.